Characterizing Language and Motor Development of Racially/Ethnically Diverse Infants and Toddlers with Down Syndrome

PROJECT SUMMARY/ABSTRACT
Down Syndrome (DS) impacts approximately 1 in about 700 babies born in the United States. Language and
motor development in DS are significantly delayed in early childhood; however, little research has investigated
how language and motor skills interact and support each other. In response to the NIH INCLUDE Down
Syndrome Research Plan, the proposed study will address several gaps in our understanding of DS. First, we
will implement multiple methods, including technology, to measure language and motor development across
direct assessments, naturalistic measurements, parent reports, and free play observations. Second, we intend
to actively recruit and enroll over 60% of participants from racially/ethnically minoritized backgrounds. Finally,
we will collect longitudinal data to track measures that may be sensitive to developmental change. Using
multiple methods, we will track developmental trajectories of language and motor skills in infants with Down
Syndrome (DS) and typically developing infants over a 12-month period. The goal is to measure language,
communication, motor skills, and physical activity to better understand how these skills develop and interact
with each other over time. If funded, we will recruit 36 infants with DS (age 6 months – 18 months) and 36
typically developing (TD) infants (age 6 months – 18 months) and follow them for 12 months. We intend to
recruit at least 60% of our sample from racial/ethnic minority backgrounds (i.e., Hispanic/Latino, Black/African
American, Asian, Native American). Infants and their caregivers will complete standardized questionnaires and
assessments at study entry, then two more times, 6 months apart, for a total of three assessments in a 12-
month period of time. This research will provide critical data on the early development of racially/ethnically
diverse infants with DS to inform intervention strategies and supports.

Public health relevance
PROJECT NARRATIVE Little is known about how language and motor skills interact in the early development of infants with Down Syndrome (DS). This project will follow infants (6 to 18 months) with and without DS for 12 months to measure language and motor trajectories using a multiple-method approach. The results from this study will inform intervention priorities and strategies to support early development in DS.